Recovery Housing for Medication Assisted Treatment - Stepping Stones

PROJECT SUMMARY/ABSTRACT Stepping Stones proposes to implement a recovery housing model customized for the 278,000 persons enrolled in Medication Assisted Treatment programs in the United States. Stepping Stones will increase MAT participation and retention, recovery self-efficacy, employment, and income. Phase 1 will demonstrate feasibility using a sample of females with opioid use disorders who are enrolled in MAT.

Public health relevance
PROJECT NARRATIVE Opioid abuse is epidemic in the United States and effective interventions are needed to promote adherence with evidence based treatment modalities. Most recovery based housing (e.g., sober living, half-way houses, Oxford Houses) discriminates against persons enrolled in the most effective treatment for opioid addiction – Medication Assisted Treatment. This project will develop a MAT friendly housing model that demonstrates long terms outcomes.